Extracting RDoC Constructs from EHR through Natural Language Processing to Predict Suicide in Youth

PROJECT SUMMARY/ABSTRACT
Suicide ranks as the second most frequent cause of death in adolescence, and the rate of
suicide among adolescents has continued to increase. Despite 50 years of research and efforts,
the prediction of suicide and suicidal thoughts and behaviors (STBs) remains difficult. Recent
studies indicate that electronic health record (EHR) data analytics can help predict the risk of
STB. The Research Domain Criteria (RDoC) provides a framework to probe transdiagnostic
domains reflecting the positive valence, the negative valence, and the sleep-wakefulness
element insomnia within the arousal and regulatory domain. These three RDoC constructs have
shown strong association with depression and anxiety disorders. However, there exists a
knowledge gap regarding the relationship and impact of RDoC measures extracted from EHR
on youth suicide attempts (SAs). Given significant changes in positive affect and cognitive
systems during childhood and adolescence, our overall goal is to assess the RDoC positive
valence, the negative valence, and the sleep-wakefulness element insomnia in youth with STBs
using machine learning and deep learning based natural language processing of EHR data.
This study will leverage the effort and resources that have been invested in previous projects
from two sites: a study on SA prediction using natural language processing and machine
learning from EHR data (n=7,670 youths) in the University of Pittsburgh Medical Center (UPMC)
hospitals; and the data collection for SA study in the Children’s Hospital of Philadelphia (CHOP)
with 567,091youths (n=3,125 attempters). The specific aims are to 1) develop and validate
extraction of summary variables from EHR using deep neural network language models for the
positive valence, the negative valence, and the sleep-wakefulness element insomnia within the
arousal and regulatory domain; 2) compare performance of the ML models developed in Aim 1
to extract the RDoC positive and negative valence and insomnia from EHR with traditional NLP
approaches; and 3) test utility of the RDoC positive and negative valence and insomnia in
prediction of suicidal behaviors. This proposed study, if successful, is the first steps towards
other RDoC domains and constructs extracted from EHR on youth SAs and translating the
obtained models to clinical settings. Dr. Tsui (CHOP) and Dr. Ryan (UPMC) have a long history
of collaboration in mental health studies using ML and NLP and have strong experience in
serving as PIs in various studies. Overall, our study has a potential to advance the field of SA
prediction that facilitates timely intervention and ultimately reduces youth suicides.

Public health relevance
The suicide rate among adolescents has continued to rise dramatically, and suicide now ranks as the second most frequent cause of death in adolescence. The proposed research aims to develop novel deep-learning natural language processing and machine learning tools that enable extraction of Research Domain Criteria (RDoC) constructs from narrative clinical notes in electronic health record data, facilitate evaluation of RDoC impact, and identify patients at risk of suicide attempts. The findings of this project are expected to translate to clinical practice and contribute to reduction of youth suicide rates.